Fragment-Based Discovery of STEP Modulators in Alzheimer's Disease Administrative Supplement

Project Summary
STriatal-Enriched tyrosine Phosphatase (STEP) is a neuron-specific protein tyrosine phosphatase (PTP) and a
novel therapeutic target for Alzheimer’s disease (AD), a debilitating neurodegenerative disorder for which no
cure currently exists. Multiple studies indicate that levels of STEP are elevated in AD and other
neurodegenerative and neuropsychiatric disorders, including Parkinson’s disease, schizophrenia, and fragile X
syndrome. The data suggest that increased STEP activity interferes with synaptic function and contributes to the
characteristic cognitive and behavioral deficits in these devastating diseases. Crossing STEP KO mice with
mouse models of AD, schizophrenia, or fragile X syndrome completely reversed the cognitive and behavioral
deficits, generating progeny with lower STEP levels indistinguishable from WT mice. Similar effects were
observed when STEP was pharmacologically inhibited by our tool compound TC-2153. These studies validate
STEP as a novel drug target for the treatment of AD and other neurodegenerative and neuropsychiatric
disorders. TC-2153 is the only reported STEP inhibitor with cellular and in vivo activity. However, TC-2153 and
similar compounds are known to react with cellular thiols and modify DNA, precluding this inhibitor from further
preclinical studies. Other reported STEP inhibitors suffer from poor selectivity for STEP and lack of efficacy under
physiological conditions. To overcome these typical challenges for inhibitors targeting PTPs - enzymes that have
a highly conserved and highly charged active site - we set out to discover small molecules that bind to less
conserved, allosteric sites in STEP. Using innovative fragment-based screening technologies, we identified 19
fragments, low molecular weight compounds adhering to the “rule of 3”, that selectively bind to novel, less
conserved sites in STEP with up to single digit micromolar affinity. These fragments are ideal starting points for
generating STEP-targeted degraders such as proteolysis targeting chimeras (PROTACs) with physicochemical
properties suitable for crossing the blood-brain barrier (BBB). In fact, in preliminary experiments we have
demonstrated that a PROTAC based on our best fragment can effectively reduce STEP levels in vivo. Based on
these exciting results, we propose a STEP-targeted protein degradation approach as a therapeutic strategy in
AD. In Aim 1, we will optimize our fragment binders for ligand efficiency and STEP selectivity. In Aim 2, we will
generate STEP PROTACs from the most promising binders, assess them in our established testing funnel, and
optimize them for drug metabolism and pharmacokinetics (DMPK), pharmacodynamics (PD), and toxicity (Tox)
properties. The goal is to generate non-toxic STEP degraders with exposure and efficacy in the brain. In Aim 3,
we will test whether candidate PROTACs are able to improve cognition in mouse AD models. Our studies are
designed to provide proof-of-concept (POC) for STEP degraders as novel therapeutics in AD. We expect to
develop at least one lead series and one backup series of effective PROTACs that are ready for preclinical
development towards a first-in-class early treatment option for AD.

Public health relevance
Project Narrative Recent evidence links synaptic dysfunction in Alzheimer’s disease (AD) to increased activity of the phosphatase STEP. Genetic deletion as well as pharmacological inhibition of STEP activity attenuates the cognitive impairment in an AD mouse model, validating STEP as a novel drug target for the treatment of AD. We propose to utilize an innovative fragment-based drug discovery approach to develop first-in-class potent, drug-like, and selective STEP proteolysis targeting chimeras (PROTACs), and to provide proof-of-concept for a STEP-targeted protein degradation strategy for the treatment of AD.